Rac-enhanced Chimeric Antigen Receptor-Macrophage (Race-CAR-M) Immunotherapy for Triple Negative Breast Cancer

Project Summary
Triple-Negative Breast Cancer (TNBC) is an aggressive subtype lacking estrogen, progesterone, and HER2
receptors, limiting targeted therapy options. Conventional systemic therapies, such as chemotherapy, are non-
specific, leading to significant toxicity. Despite the success of Chimeric Antigen Receptor T-cell (CAR-T)
therapy in hematologic cancers, its use in solid tumors like TNBC is hindered by challenges such as an antigen
heterogeneity, immunosuppressive tumor microenvironment (TME), and limited T-cell infiltration. Macrophages
can engulf pathogens, dying cells, and cancer cells and naturally infiltrate TME. An innovative approach
involves engineering macrophages to express Chimeric Antigen Receptor (CAR) that specifically target
antigens on cancer cells, thereby creating CAR-Macrophages (CAR-Ms). This project aims to develop and
evaluate a novel CAR-M therapy targeting Chondroitin Sulfate Proteoglycan 4 (CSPG4), overexpressed in
TNBC. Our earlier findings demonstrated that co-expression of an active form of Rac2 (Rac2E62K) with a CAR
enables macrophages to specifically recognize and engulf living target cancer cells. Hence, Rac2 activation in
anti-CSPG4 CAR-Ms is proposed to enhance tumor-infiltrating and phagocytic capabilities, leading to improved
tumor targeting and eradication. This study aims to evaluate the specificity, efficacy, and impact on
angiogenesis of anti-CSPG4, Rac-enhanced CAR-Ms (Race-CAR-Ms) using the chicken chorioallantoic
membrane (CAM) model. The CAM model will facilitate detailed in vivo analyses, including tumor infiltration,
tumor regression, and metastatic dissemination. Additionally, the anti-angiogenic potential of anti-CSPG4
Race-CAR-Ms will be investigated by measuring levels of proangiogenic factors and visualizing blood vessel
formation through advanced imaging techniques. Optimizing the engulfment potential of anti-CSPG4 Race-
CAR-Ms in the TNBC microenvironment requires a thorough understanding of their energy requirements and
metabolic flexibility. Hence, the project focuses on metabolic profiling of anti-CSPG4 Race-CAR-Ms. Liquid
chromatography-mass spectrometry (LC-MS) and flow cytometry-based metabolic assays will be used to
identify key metabolic pathways and assess reactive oxygen species (ROS) production. The proposed
research integrates advanced imaging, molecular biology techniques, and metabolic assays to elucidate the
therapeutic potential anti-CSPG4 Race-CAR-Ms in TNBC. The outcomes are expected to provide significant
insights into the efficacy and specificity of anti-CSPG4 Race-CAR-M therapy for TNBC and has the potential to
contribute to the development of targeted immunotherapy for aggressive TNBC.

Public health relevance
Triple-Negative Breast Cancer (TNBC) poses a significant public health challenge due to its aggressive nature and lack of targeted therapies. This research aims to develop an innovative immunotherapeutic strategy using Rac-enhanced Chimeric Antigen Receptor-Macrophages (Race-CAR-M) targeting Chondroitin Sulfate Proteoglycan 4 (CSPG4), a marker overexpressed in TNBC. This approach aims to boost the tumor-infiltrating and engulfment abilities of macrophages and understanding their metabolic adaptations within the TNBC tumor microenvironment, potentially providing a targeted therapy to improve health outcomes for TNBC.